Veteran Kidney Dietary Adherence Associations with Kidney-Related Outcomes and Patient Perspectives, Experiences, and Perceptions with Diet and Medically Tailored Meals (KDA-MTM study)

Veterans experience high prevalence rates of chronic kidney disease (CKD) with notably accelerated
progression to end-stage kidney disease is. Veterans who have CKD and other comorbidities exhibit higher
mortality rates than the general U.S. population. CKD is frequently either caused by or associated with
hypertension, and diabetes. Lifestyle changes, such as diet, may assist in preventing, delaying, or limiting the
severity of hypertension, diabetes, and/or kidney disease. Medically tailored meals (MTMs) represent an
emerging and innovative approach at the intersection of healthcare and nutrition for managing chronic
diseases such as CKD. MTMs are aligned with national nutritional standards and recommendations,
specifically addressing the unique dietary needs of individuals. This holistic approach encompasses a
multifaceted strategy that goes beyond addressing clinical nutrition, outcomes, and reducing healthcare costs
to confronting broader issues like Veteran well-being or food insecurity. This is particularly relevant in the
context of CKD, where consistent adherence to dietary guidelines often proves challenging and restrictive.
Veterans with CKD may also face unique, service-related, challenges to healthy eating behaviors in addition to
these complex dietary considerations. Before diet or MTM interventions can be developed for Veterans,
preliminary associations with clinical outcomes need to be examined and Veteran-centered patient
perspectives need to be understood. The long-term goal of this line of research is to implement sustainable,
novel dietary interventions in the context of chronic, nutritionally sensitive, illnesses that are personalized for
Veterans. This encompasses examining the evidence behind CKD dietary guidelines and the potential for
liberalizing these restrictions, aiming for a balance between clinical needs and quality of life through greater
dietary flexibility. The initial steps toward the long-term goal are proposed with this study, in three aims, using
an observational cohort, cross-sectional cohort, and a multi-methods design: (1) score and describe kidney diet
quality and adherence in Veteran patients with CKD in a nationally representative dataset, (2) determine the
relationship of diet with clinical biomarkers and measures in these Veterans with CKD, (3a) understand patient
perspectives and experiences with dietary habits, eating behaviors, and kidney diets, (3b) understand barriers
and facilitators to kidney diet MTMs, as well as perceived meal effectiveness and acceptability, among
Veterans with CKD. The quantitative aspects (Aims 1 and 2) of this research proposal will provide evidence on
how Veterans align or deviate from nutritional recommendations globally and how diet quality relates to clinical
outcomes for potential effects sizes and calculating statistical power for a future clinical trial. The qualitative
Aim 3 will provide a greater understanding of Veterans dietary and nutrition practices and perspectives in the
context of kidney disease, the home-environment, and the greater external-community setting, as well as MTM
access and perceived benefits of MTMs. This CDA-1 proposal is supported by infrastructure and resources
from the Denver Center of Innovation (COIN) and Merit awards led by the mentoring team. The data gathered
from this study will inform the development of a dietary or MTM intervention trial (future CDA-2 study) for
Veterans with CKD. During the award period, the candidate will take full advantage of the allocated research
time to develop clinical, research, and professional skills essential for a future role as a VA independent
investigator. Specifically, the candidate will enhance their skills in both quantitative and qualitative research
methodologies, focus on research tailored to the health of Veterans, and refine their abilities in scientific
communication, including dissemination of their findings.

Public health relevance
Chronic kidney disease (CKD) is a significant, higher prevalence health issue among Veterans that often coexists with or exacerbates comorbidities such as heart disease and diabetes. Furthermore, Veterans are at higher risk of poor nutrition and unique service-related factors influencing diet. Lifestyle factors, such as diet, play an important role in potentially preventing, delaying, or alleviating the severity of chronic diseases. Medically tailored meals (MTMs) are specially formulated meals to meet complex nutritional needs in chronic diseases. The proposed research applies novels methods of personalized diet scoring to nutritional recommendation standards and evaluating the relationship between diet and disease, while gathering Veteran patient experiences with diet and perceptions of MTMs. The study will inform individualized nutrition care for Veterans with CKD and can serve as a model of other methods to study nutrition sensitive diseases among Veterans.